Flow regulation of the Alk1/Eng pathway in vascular homeostasis and disease

PROJECT SUMMARY
Fluid shear stress-dependent vessel remodeling is an essential regulatory mechanism in embryonic
development and in adult vascular homeostasis where it optimizes blood flow to target tissues. Conversely, un-
or mis-regulated remodeling results in vascular malformations, while poor remodeling is a key aspect of blood
flow restriction in coronary and periphery artery disease. Our preliminary data reveal the existence of a regulatory
network with two mutually inhibitory states, one associated with vessel stability and one with physiological
outward remodeling or pathological AVM formation. These results allow us to propose a unifying hypothesis that
links physiological and pathological remodeling, and suggest the existence of control points that can be
manipulated to either increase or decrease vascular lumen diameter. The project aims to elucidate these
regulatory mechanisms and then harness these new insights to investigate their relevance to vascular
development, to identify therapeutic targets for HHT patients who suffer from excessive pathological remodeling,
and identify therapeutic targets for coronary and peripheral artery disease patients where physiological
remodeling is impaired. We will define the molecular basis of this novel EC shear stress mechanism, determine
its biological role and develop and test therapeutic applications based on this knowledge.

Public health relevance
PROJECT NARRATIVE The hypothesis that drives this proposal is dysregulation of the fluid shear stress (FSS) mechanotransduction pathways that drive physiological flow-dependent remodeling can lead to pathological remodeling in vascular malformations in hereditary hemorrhagic telangiectasia (HHT) or to failed remodeling in coronary and peripheral artery disease in patients. Elucidating this regulatory network will allow its effective manipulation to either decrease or increase vascular lumen diameter, thereby improving outcomes in HHT patients who suffer from excessive pathological remodeling, and from patients with coronary and peripheral artery disease where physiological remodeling is impaired.